ALZHEIMER'S REGISTRY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this registry is to establish and maintain a group of well-characterized, potential research participants willing to participate in future research involving Alzheimer's and memory.